Atlas Neurosurgical Navigation System for Low-Resource Settings

Project Summary
Traumatic brain injuries (TBI) comprising trauma, subarachnoid hemorrhage, and acute hydrocephalus are
neurological emergencies that often require the intervention of a neurosurgeon. Annually, 5.48 million suffer from
TBI globally, leading to an economic burden of $37.8 billion annually. Severe TBI occurs more often in low-to-
middle income countries (LMIC), leading to increased TBI burden shouldered by these regions of the world. Life-
saving treatment for TBI commonly begins with placement of an external ventricular drain (EVD), a catheter that
drains fluid from the brain ventricles that has the potential to temporarily stabilize the patient by reducing pressure
within the skull. Most LMIC lack critical resources and access to neurosurgeons, making severe TBI a leading
cause of trauma-induced death. Developing an EVD placement approach that is accessible for emergency care
providers has potential to reduce death from preventable causes, particularly in LMIC.
This proposal aims to address a global disparity of access to neurosurgery by constructing a low-cost surgical
instrument for real-time surgical navigation and EVD placement that is accessible to LMIC, rural hospitals, and
military settings. The instrument will rigidly connect to an injured patient’s skull and act as a coordinate measuring
system. The device will register to preoperative imaging and visually guide the operator through the steps of the
EVD placement workflow. System accuracy will be tested using novel human ventricular simulators designed
specifically for measuring EVD placement. Measurements will be taken with respect to a known target location
inside the simulators, allowing for accuracy to be assessed. The research team will then test placement by a
variety of care providers in the simulators, with measurements taken using magnetic resonance imaging.
The device will be a linear four degrees-of-freedom arm operated with hand-guidance. It will be constructed
from aluminum with a stainless steel self-tapping hollow bolt to connect the device to a 10mm skull burr hole.
Four encoders will relay their position to a battery-powered Raspberry Pi, communicating wirelessly to a
computer’s visualization software. An EVD will attach to the effector of the system with a known offset from the
tip, and the operator will guide the drain through the burr hole under visualization into the target ventricle of the
brain to achieve adequate drainage. This complete system will be designed to cost less than $5,000 USD at
production scale and be capable of guiding an operator through the surgical workflow, allowing for improved
access to neurosurgical stabilization treatment even in the absence of a neurosurgeon. The principles of this
new type of navigation, named kinematic navigation, will be further explored in additional medical procedures
to assess generalizability of its use. The same system used for intracranial pressure relief described above will
be used to additionally guide tumor biopsy. Finally, a system with five degrees of freedom will be constructed
using five axes to assess the feasibility of using kinematic navigation in image-guided spine surgery.

Public health relevance
Project Narrative Severe increased intracranial pressure results in high levels of death and disability for affected individuals, particularly in low-income environments such as rural settings and regions lacking access to neurosurgical care. In this proposal, we aim to develop novel kinematic navigation tools and workflows that will enable first- responding doctors to provide emergency stabilizing treatment to affected individuals in need of transport to hospitals with access to neurosurgical care. We additionally aim to deeply investigate the principles of these new kinematic tools for other surgical approaches including brain biopsy and spine surgery.